Investigating how sequentially acting cues guide long-distance cell migration in vivo within embryos

SUMMARY
Collective cell migration is essential to the progression of normal embryonic development and organogenesis,
and is a tightly-regulated process that can involve the interplay between two or more signaling pathways to
drive forward movement of cell cohorts. Additionally, patterning an organ often requires selective apoptosis
and compensatory proliferation of cells. Errors in collective migration and cell death programs can have serious
consequences, including complete developmental arrest, abnormal organ function, and tumorigenesis. In this
proposed research plan, we will use the Drosophila embryonic caudal visceral mesoderm (CVM), a small
population of muscle precursor cells that undergo highly stereotyped directional movement, as a model for
collective cell migration and survival. As the longest migration of embryogenesis, CVM cells must receive input
via signaling cues from other cells in order to navigate the changing environment of the developing embryo.
We have previously determined an important role for FGF signaling as both chemotropic and survival cue, and
that FGF receptor is specifically expressed in a subset of migratory cells. However, loss of FGF signaling does
not completely ablate collective migration, suggesting the existence of additional, as-of-yet uncharacterized
cues. The objective of this study is to gain a comprehensive understanding of the spatiotemporally-regulated
cues that guide directional movement of the CVM, and subsequent survival or apoptosis of distinct subsets of
cells. Our central hypothesis is that FGF signaling cooperates with additional signaling cues in order to drive
forward movement and cell survival, and involves defining specialized subsets of cells within each CVM cohort
to promote spatial organization driving forward movement. To test this hypothesis, we will pursue the following
specific aims: (AIM 1) Investigate roles for spatially-localized genes within the migrating CVM collective in
promoting cell migration; (AIM 2) Investigate mechanism of CVM attraction to PGCs; and (AIM 3) Investigate
the relationship between BMP and FGF signaling in regulating CVM cell migration and survival. To accomplish
these aims, we will employ an innovative combination of established genetics and immunostaining techniques
with elegant optogenetics and in vivo live imaging approaches to manipulate and visualize migratory cells, as
well as quantify spatiotemporal activation of the cell death program. We believe this study is significant
because it would not only demonstrate a mechanism for signaling cross-talk in an emerging yet
poorly-characterized cell migration system, but considering the large number of functions and diseases
attributed to signaling pathways such as BMP and FGF, elucidating the interaction between multiple pathways
in the context of the genetically-tractable and conserved Drosophila model system has the potential to identify
more specific therapeutic targets. Therefore, this study will be impactful by contributing to a more
comprehensive understanding of collective cell migration, the mechanisms underlying organogenesis, as well
as the cell migration and survival programs implicated in normal development and cancer.

Public health relevance
NARRATIVE The research program proposed here will provide insights into the guidance cues that support long-distance collective migration of the caudal visceral mesoderm (CVM) in the Drosophila embryo, a process that is required for the assembly of the midgut musculature. Due to the similarities between CVM development and intestinal smooth muscle cell (ISMC) specification in vertebrates, studying CVM cell migration has the potential to provide insight into the basis for human congenital defects such as familial visceral myopathy (FVM). Furthermore, anoikis, or the programmed cell death (PCD) of migrating cells that have detached or adhered to an inappropriate substrate, has been observed in CVM cells; as anoikis resistance is a hallmark of metastatic cancer, the CVM cell migration model has the potential to provide widely-applicable insights into the developmental and pathological mechanisms governing organogenesis and disease.